Ovarian Inflammaging as a Mechanism for Ovarian Cancer

PROJECT SUMMARY
High-grade serous ovarian carcinoma (HGSOC) is the most lethal cancer of the female reproductive system with
less than 50% of patients surviving 5 years after diagnosis. A woman’s total lifetime number of ovulations is a
key risk factor for developing ovarian cancer, and factors that repress ovulation including use of oral
contraceptives significantly reduce HGSOC incidence. Despite the association with ovulation, HGSOC typically
presents as late-stage, metastatic cancer in post-menopausal women who are no longer ovulating. Therefore, a
major question in the field is: how do ovulation during a woman’s reproductive prime and the aging ovary post-
menopause contribute to ovarian cancer development. Here, I propose two distinct aspects of the aging ovarian
microenvironment that promote HGSOC initiation and pathogenesis. First, follicular fluid, which becomes fibro-
inflammatory with advanced reproductive age, triggers tumor initiation in the fallopian tube epithelium (FTE).
Second, changes to the composition and biomechanics of the aging ovarian extracellular matrix (ECM) allow for
enhanced tumor cell adhesion and invasion. Recent data suggest that HGSOC tumors arise from the FTE, and
exposure to follicular fluid results in DNA damage in FTE cells both in vivo and in vitro. However, the direct effect
of reproductive aging on FTE tumorigenesis has not been examined. Work from our lab has identified a series
of fibro-inflammatory cytokines that increase in human follicular fluid with advanced reproductive age, including
VEGF which has roles in HGSOC metastasis and is involved in tumor initiation in other organ systems. In Aim 1
of this proposal, I will test the hypothesis that follicular fluid induces neoplastic transformation of the FTE in an
age-dependent manner, through the action of candidate cytokine VEGF. I will treat FTE cell lines with human
follicular fluid across an aging continuum or a dose-curve of recombinant-human VEGF to determine effects to
cell proliferation, DNA damage, oxidative stress, and global gene expression. After tumor initiation in the FTE,
tumor cells migrate to the ovary for expansion. Work from our lab has characterized significant changes to the
composition of the ovarian ECM with advanced reproductive age including increased levels of collagen I and III,
which increase tissue stiffness. HGSOC cells have been shown to favor a 3D collagen-rich matrix for expansion
and stiffer matrices are known to increase cancer cell motility. In Aim 2, I will determine the mechanism by which
the tissue environment of the aging ovarian ECM promotes HGSOC pathogenesis by investigating the
independent functions of ECM composition and ovarian tissue stiffness on HGSOC cell adhesion and invasion.
To this end, I will assess in vitro HGSOC cell adhesion and invasion on hydrogels that recapitulate the stiffness
and collagen abundance of the aging ovary. Furthermore, I will evaluate HGSOC cell adhesion and invasion in
reproductively young and old decellularized mouse ovaries ex vivo, as well as an in vivo after transplantation
into reproductively young and old hosts. Taken together, these studies will provide mechanistic insight into how
ovulation and the aging ovary contribute to HGSOC and identify key pathways as therapeutic targets.

Public health relevance
PROJECT NARRATIVE The total lifetime number of ovulations is a key risk factor for high-grade serous ovarian cancer (HGSOC), yet HGSOC typically presents as late-stage, metastatic cancer in post-menopausal women who are no longer ovulating. I propose that exposure to follicular fluid upon ovulation triggers tumor initiation in the fallopian tube epithelium in an age-dependent manner and tumor cell adhesion and invasion preferentially occur in the aging ovarian stroma. Overall, the proposed studies will provide insight into how ovulation and the aging ovarian microenvironment contribute to ovarian cancer and will identify key fibro-inflammatory pathways as putative biomarkers and therapeutic targets.